Directly measuring synaptic and population coupling in cortex during perception

Directly measuring synaptic and population coupling in cortex during perception
The cerebral cortex is the defining brain structure of mammals and underlies our most complex sensory
behaviors. A major need exists to identify how synaptic and network mechanisms in cortex lead to normal and
impaired sensory perception and behavior. A prevailing model of cortical function postulates that synaptic
excitation (E) and inhibition (I) exhibit a stable balance (E/I balance) that is disrupted during sensory impairments
and neurodevelopmental diseases. Currently, there is no knowledge regarding synaptic E/I balance during
sensory perception, nor its relationship to large-scale neural network activity. We are uniquely positioned to
bridge this critical knowledge gap with an innovative combination of whole-cell patch-clamp and large-scale
population recordings of defined excitatory and inhibitory neurons during visual perception in mice. This multi-
scale approach will enable us to 1) Define how excitatory and inhibitory neuron populations spanning cortical
layers predict the accuracy of visual perception 2) Reveal synaptic mechanisms that underlie visual perception
3) Define the relationship between excitatory and inhibitory population activity and synaptic mechanisms
engaged by visual perception.
SIGNIFICANCE. This project will meet a significant need to understand how excitatory and inhibitory activity in
cortex is coordinated at the synaptic, network, and behavioral levels to support sensory perception. It is
imperative to understand these processes in individual neurons, networks, and their synaptic inputs during
behavior, so that we may better comprehend how to rectify sensory processing deficits characteristic of many
neurological and neurodevelopmental disorders.
INNOVATION. This project will provide innovative measurements and analysis of the relationship between
single-neuron synaptic inputs and large-scale neural network activity during controlled perceptual behaviors.
This combination of techniques will allow critical assessment of long-standing theories of cortical function (E/I
balance) that require validation in relevant behavioral contexts. These results will provide conceptual innovation
by detailing how inhibition sculpts and coordinates excitatory activity in cortex to orchestrate perceptual
behaviors.

Public health relevance
Project Narrative The brain processes sensory information rapidly during behavior. Impairments in sensory processing characterize many debilitating neurological conditions such as schizophrenia, dementia, and autism, and we lack effective treatments for such disorders because we do not fully understand the principles of neuronal communication. Discovering these principles is a fundamental step towards lessening deficits common to many neurological disorders.